Neural foundations of learning, reasoning, and surprise in human infants

How is the human brain organized to learn and reason about the world during development? Although
young infants show behavioral signs of surprise (e.g. longer looking) at unexpected stimuli (e.g.
upon hearing a completely new word, seeing an object float in midair, or seeing a person perform an
inefficient action) (Gergely & Csibra, 2003; Saffran, Aslin, & Newport, 1996; Spelke, Breinlinger,
Macomber, & Jacobson, 1992; Spelke & Kinzler, 2007), the neural systems that support their
expectation and surprise are not accessible through measurements of behavior. In this proposal, we
use an infant-friendly, non-invasive neuroimaging technique, functional near-infrared spectroscopy
(fNIRS), to investigate the neural systems that allow infants and adults to form expectations and
detect violations of those expectations across different situations. We test the hypotheses that
sensory cortex encode task- and modality specific information during learning, that lateral
prefrontal cortex (LPFC) detects subsequent violations of those expectations, and that LPFC drives
attention towards the surprising stimulus. If so, we should find differentiated sensory activity
during learning across tasks, but overlapping LPFC activity during surprise in those tasks, which
should in turn predict behavior. Aim 1 tests these predictions using learning tasks, wherein people
form new expectations in the lab (e.g. about which word, 'doti' or 'lado', is more likely to come
from a newly learned artificial language) (Marcus, 1999; Saffran et al., 1996). Aim 2 investigates
the same predictions in tasks requiring prior expectations about objects (that they're solid),
people (that they behave rationally), and probability (that randomly drawn samples tend to be
representative of the population) (Gergely & Csibra, 2003; Spelke et al., 1992; Spelke & Kinzler,
2007; Xu & Garcia, 2008). Aim 3 compares the neural systems that allow people to learn new
expectations (Aim 1) and reason using prior expectations (Aim 2). Across all aims, we will test
infants and adults in multiple tasks (e.g. one task involving people, another involving objects),
compare neural activity during learning and surprise in those tasks, and use this neural activity
to predict behavior. The proposed research takes an innovative, cross-disciplinary approach to push
the frontiers of our theories of how the brain is organized to enable such rapid and rich learning
across development. Its findings will reveal (1) which regions of the brain are implicated in
forming expectations and having those expectations violated, (2) whether those cortical regions
support a general, broad process of belief formation or task- and modality-specific learning, and
(3) how they modulate behavior in infants and adults. Thus, this work has the potential to
transform our understanding of how infants learn and reason in and out of the lab. To know how to
nurture learning and reasoning, during both typical and atypical development, we need a causal
theoretical understanding of how learning and reasoning work in the mind and brain. This work takes
strides towards this goal by providing benchmarks and measures for designing and evaluating
targeted educational and parenting interventions.

Public health relevance
In this proposal, we investigate the neural systems that enable infants' incredible ability to learn language, form expectations about objects and people, and detect violations of these expectations, and link activity in these systems to infant behavior. Developmental disorders such as autism spectrum disorder and others can impact our capacities to learn and reason in many different ways (e.g., deficits in learning from social information, reasoning about mental states, recognizing actions like pointing and looking as informative), but we are still far from a causal theoretical understanding of the mental and neural systems that support our basic abilities to learn and reason, and thus we cannot yet quantify how developmental disorders affect them. The proposed work aims to fill this gap by identifying the neural and behavioral signatures of infants' learning and reasoning across many domains, which will inform the development of effective, targeted interventions.